Molecular Mechanisms Underlying E-cadherin Mechanotransduction

PROJECT SUMMARY
All cells and organisms are subjected to mechanical forces. These forces are sensed by cell
surface receptors, such as the epithelial (E)-cadherin, which links cells to their neighbors. E-
cadherin responds to force by activating signaling pathways inside the cell. These pathways
trigger the formation of new cell-cell adhesions and stimulate the rearrangement and
reinforcement of the actin cytoskeleton. These actin cytoskeletal rearrangements are
energetically costly. We discovered that the energy required to fuel the cytoskeletal
rearrangements is provided by AMP-activated protein kinase (AMPK). AMPK is a master
regulator of metabolism. It is activated when force is applied to E-cadherin and signals for ATP.
The ATP fuels the cytoskeletal changes necessary for cells to resist external forces. In this
renewal, our goal is to advance the paradigm for how mechanotransduction and metabolism are
coordinated. We will address how: (1) force stimulates glucose metabolism, (2) glycolysis
localized to regions of the cell where the actin cytoskeleton is reinforced, (3) actin is
polymerized to allow for cytoskeletal reinforcement, and (4) the uncoupling of metabolism and
mechanotransduction affects physiology. When this work is complete, significant advances in
understanding of the linkages between mechanotransduction and metabolism will emerge. Our
proposed animal studies examining uncoupling mechanotransduction and metabolism in vivo
have the potential to provide new insight into physiology. The use of sophisticated assays will
provide a novel understanding of the relationship between metabolic enzymes and the actin
cytoskeleton. These studies, combined with our conceptually innovative observation that PFK-M
is the only force sensitive PFK1 isoform, have the potential to call for a re-evaluation of
published work and are key to informing the nature of the defects that might be present in
disease.

Public health relevance
NARRATIVE Several diseases are associated with changes in the response of cells to force and altered cell metabolism, but little is known about how these two processes are coordinated. The work in this proposal will provide an understanding for how the response to force is linked to cell metabolism. This information will provide mechanistic insight into the etiology and progression diseases, ranging from muscular dystrophies and cardiomyopathies to cancer.